Administration

CANCER CENTER ADMINISTRATION
PROJECT SUMMARY/ABSTRACT
The vision of the Chao Family Comprehensive Cancer Center (CFCCC) is to “Prevent, Manage and Cure Cancer
so that All People Live Healthier, Longer Lives.” The mission parallels that of UC Irvine (UCI), the parent
institution, to Discover, Teach, and Heal within the broad discipline of cancer medicine.
CFCCC Administration is directed by the Associate Director for Administration and Finance, Christine Hui, MPH.
She serves as a Cancer Center senior leader and reports directly to the Cancer Center Director. Administration
provides effective centralized organization, infrastructure, and support that enables the CFCCC to function
efficiently and cohesively in line with the CFCCC's mission. Administration works with leadership to foster
scientific and intra-institutional collaborations to support cancer-focused research, strategic goals, and the
CFCCC mission and vision. Administration oversees the management of programmatic membership, strategic
planning, leadership meetings and scientific retreats, coordination and management of pilot project competitions,
coordination of all Cancer Center Support Grant (CCSG) data management and reporting, space management,
participation with faculty recruiting and onboarding, and fiscal control and management of all accounts ensuring
compliance with all UCI institutional policies and federal requirements.
Administration also provides centralized clinical research infrastructure through the Sue and Ralph Stern Center
for Cancer Clinical Trials and Research (Stern Center), which reports to the Associate Director for Administration
and Finance. This support includes managing the trials from activation to close-out, budget and contract
negotiation, and study and data management. Staffing and coordination for clinical research review committees,
including the Disease-Oriented Teams, Protocol Review and Monitoring Committee, and Data and Safety
Monitoring Board are also managed through the Stern Center.
The majority of the costs for support of Administration are covered by institutionally-provided discretionary funds
under the authority of the CFCCC Director. The Administration Core budget request represents 9% of the overall
CCSG budget.

Public health relevance
CANCER CENTER ADMINISTRATION PROJECT NARRATIVE Per PAR-20-043, a Project Narrative is not required for this component.